Association of diuretics with change in extracellular volume, natriuretic peptides, symptoms, and cardiovascular outcomes in CKD

I am a Nephrologist and junior clinical researcher at the Michael E. DeBakey VA Medical Center, an
academic VA medical center affiliated with the HSR&D Center for Innovations in Quality, Effectiveness and
Safety. My long-term career goal is to become an independent VA clinical researcher focused on improving
cardiovascular (CV) and kidney outcomes in Veterans with chronic kidney disease (CKD). My short-term goals
are to conduct initial studies to determine the effects of diuretics on relationships between extracellular volume
(ECV), brain natriuretic peptide (BNP) and N-terminal-pro-BNP (NT-pro-BNP), symptoms, CV hemodynamic
parameters, and outcomes in Veterans with CKD, and to complete training in conducting a clinical trial, CV
and cardiorenal study design, use of bioimpedance spectroscopy (BIS) measurements of ECV, and advanced
scientific appraisal. To complete the proposed projects and to ensure that I have the training to compete for VA
Merit Review, I have designed a comprehensive plan including hands-on mentorship, coursework, conference
attendance, and experiential learning to address these specific content areas. I have assembled a diverse team
of mentors dedicated to my career development to oversee the scientific and training aims of this proposal.
We will use a translational science model to address our central hypothesis, that starting or increasing
diuretics in Veterans with CKD is associated with changes in patient-level factors, CV physiology, and
population-level outcomes. In the first study, we will determine if initiation of diuretic treatment or increase in
dose is associated with changes in BNP and NT-pro-BNP, patient-reported symptom burden, and short-term
hemodynamic parameters in patients with CKD stages 1-3 and elevated blood pressure, and whether these
changes correlate with changes in ECV. This clinical trial will include 46 outpatients with CKD stages 1-3 and
blood pressure >140/90 mmHg. ECV will be measured by BIS, which is a validated, non-invasive, painless
measure of ECV. Plasma BNP and NT-pro-BNP will be measured, and patient-reported fatigue, depression,
and quality of life will be quantified using validated questionnaires. Hemodynamic parameters include blood
pressure, pulse pressure, total peripheral resistance index, and cardiac index measured by Non-Invasive
Cardiac Output Monitoring. A transthoracic echocardiogram will measure left ventricular mass index, valvular
disease, and diastolic dysfunction. At the first visit, I will initiate or increase the dose of a thiazide or loop
diuretic. Study measures other than echocardiogram will be repeated 4 weeks after the intervention to
determine changes in these parameters. We will compare the changes in natriuretic peptides, symptoms, and
CV parameters with the change in ECV. Second, we will determine whether initiation of a diuretic vs. non-
diuretic is associated with CV and kidney outcomes in patients with CKD stages 1-3 and 4-5 using a large, real-
world database of Veterans with CKD. It is considered standard of care that people with CKD should be
prescribed an angiotensin converting enzyme inhibitor (ACEi) or angiotensin receptor blocker (ARB) as first-
line treatment for high blood pressure. However, many individuals with CKD wind up needing additional anti-
hypertensive medications, and the best choice of a second-line agent remains unclear. We will address this
question in a retrospective cohort study using the Corporate Data Warehouse database. We will identify
individuals with CKD who were prescribed an ACEi or ARB as their first blood pressure agent, and then
compare CV outcomes between those whose second agent was a diuretic or a non-diuretic.
These projects will build on knowledge from animal and human studies and identify relationships
between ECV, natriuretic peptides, symptom burden, and CV disease in patients with CKD, particularly in
stages 1-3, when preventive interventions may have the greatest impact. The proposed training plan will ensure
successful completion of these projects. Ultimately the knowledge gained from these studies will support VA
Merit applications to determine whether natriuretic peptides can guide diuretic therapy in patients with CKD.

Public health relevance
Almost 15% of Americans have chronic kidney disease (CKD), with an even higher rate in Veterans due to common risk factors such as high blood pressure and diabetes. People with CKD have a high risk of cardiovascular (CV) diseases, such as heart attacks, heart failure, and strokes. Extra fluid in the body, called volume overload, may lead to CV disease in people with CKD. It is unknown if volume overload develops in the earliest stages of CKD, when treating it with common, inexpensive medicines called diuretics may improve long-term CV outcomes. The first study will lay important groundwork to answer this question in Veterans with early CKD by comparing two ways to measure volume overload and studying the change in common symptoms like fatigue and short-term CV function after treatment with diuretic medicines. The second study will look at past medical records to determine if lowering blood pressure with diuretic medicines was associated with less CV disease in Veterans with CKD, which could affect choices of blood pressure medicine in patients with CKD.